A Closed Loop Control System with Live Cells in the Loop

A CLOSED LOOP CONTROL SYSTEM WITH LIVE CELLS IN THE LOOP
This work proposes to develop and apply, for the ﬁrst time, control theory-derived strategies to regulate autophagy in live
cells using an innovative experimental testbed with sensing and actuating capabilities. Combinations of pharmacological
interventions are used extensively for the treatment of many diseases. Therefore, there is signiﬁcant potential for control theory-
based treatments to enhance the well-being of patients through careful tuning of dosage delivery of multiple pharmacological
reagents (PRs). Intracellular measurements of the formation of autophagy vesicles (AVs) in response to the application
of various PRs will be conducted using traditional ﬂuorescence microscopy and an Amnis ImageStream Mark II Imaging
Flow Cytometer, available at the University of New Mexico (UNM) Autophagy, Inﬂammation, and Metabolism in Disease
Center of Biomedical Research Excellence (AIM Center), the only autophagy-focused CoBRE in the nation and in which
PI Sorrentino is an Associate Member. This state-of-the-art instrument uses ﬂow cytometry and multispectral imaging to
detect intracellular AVs, providing an accurate count of total AVs (the output) within individual cells. A perfusive ﬂuidic
delivery system to deliver drugs (the inputs) in time and in a controlled manner will be developed as part of the proposed
eﬀort. This experimental testbed will provide a proof-of-concept realization of closed-loop control of autophagy in live-cell
experiments. In addition, an integrated mathematical model will be developed to describe the regulation of autophagy in
live cells by considering the eﬀects of several PRs on the formation of AVs. Our control decisions will be explicated at two
levels: ﬁrst, the choice of PRs to use in a combination study out of a set of available PRs; and second, the dosage function
for each PR in the combination, i.e., the rate at which the PR is supplied as a function of time, with time being a continuous
function. An innovative multi-scenario optimal controller will also be developed and tested to optimize the control actions in
the presence of limited experimental information and uncertainty about the state of the system.
The UNM AIM Center hosts a team of specialists who conduct groundbreaking research into the role of autophagy in
inﬂammatory diseases and infection, and who provide mentoring opportunities for junior faculty. As an Associate Member
of the AIM Center, PI Sorrentino is in a unique position within a specialized, local environment to meet with success. The
long-term impact of the proposed research will be signiﬁcant, as it has considerable potential to advance scientiﬁc knowledge
at the nexus of engineering and life sciences, and lead to the development of optimized therapies that could positively aﬀect
the well-being of millions of patients worldwide.
1

Public health relevance
PROJECT NARRATIVE This research will infuse new and innovative ideas, techniques, and perspectives from control engineering and mathematics to create an integrated model encompassing a cell signaling network known to be central in autophagy, and a set of pharmaceutical reagents that interact with this network. An innovative experimental setup with sensing and actuating capabilities will be developed and used to apply control theory-derived strategies to regulate autophagy in live cells. The long- term impact of this work will advance scientific knowledge and have significant and important consequences for optimized combination drug therapies that will positively affect the well-being of patients worldwide. 1